Fumarates for Alcoholic Liver Disease

Abstract
Alcoholic liver disease (ALD) remains the leading lethal liver condition, and the primary reason
for transplantation. There is still no effective therapy. Dimethyl fumarate (DMF), a monomethyl
fumarate (MMF) prodrug, is an FDA proved therapy for neural degenerative diseases and has
We have developed a novel
analogue molecule nicotinamide fumarate (NMF) that carries optimized pharmacokinetic
characters. Our preliminary data show that NMF significantly ameliorates alcoholic liver injury in
mice, and is superior to DMF.
been recently reported to rescue alcoholic liver injury in mice.
We propose that NMF elicits its protection via three pathways:
Nrf2-driven anti-oxidative reaction, Hca2-mediated anti-inflammatory response, and
mitochondrial induction. In this study, we will evaluate the preventive and therapeutic efficacy of
NMF comparing with RTA408 a drug solely inducing Nrf2, using mouse models of ALD. We will
also identify the mechanistic signaling by focusing on Nrf2, Hca2 and mitochondrial functions.
The study may lead to the development of new therapeutic modalities and translational studies
in the future.

Public health relevance
PROJECT NARRATIVE With no effective treatment, alcoholic liver disease (ALD) remains the leading cause of liver-related death, and the most frequent motivation for liver transplantation. In the current study, we evaluate 3 ALD-protective mechanisms, Nrf2, Hca2, and mitochondrial biogenesis elicited by a novel fumarate prodrug NMF and the Nrf2 inducer RTA408 in mouse ALD models. These studies will elucidate the relative importance of these protective mechanisms in ALD and could lead to better designs of novel therapeutic strategies.